EFFICACY TRIAL OF VOGLIBOSE (A)-1128 2 MG IN TYPE II DIABETES

The objective of this study is to compare the effectiveness and safety of voglibose with placebo in the treatment of high blood sugar in the effort to develop a new treatment for NIDDM.